Administrative Core

PROJECT SUMMARY/ABSTRACT
The Administrative Core will provide the organizational base for all UAB ADRC activities. To support
accomplishing the ADRC’s scientific goals and the continued development of the center during the exploratory
phase, we propose the following Administrative Core aims: to provide sound leadership, strategic planning,
and organizational structure for ADRC operations; to establish and coordinate meetings of Internal and
External Advisory Committees to provide evaluation, guidance, and support to ADRC leadership; to ensure
efficient, accurate, and secure management of ADRC data; to facilitate transition to local leadership of the
Neuropathology Core; to manage resource allocation and secure institutional support for ADRC activities; to
foster and enable AD research at UAB by sponsoring seminars, symposia, and interdisciplinary conferences
focusing on the latest developments in the field; to promote ADRC scientific interactions and sharing of Center
resources with national Alzheimer’s disease research initiatives, including NACC, NCRAD, and NIAGADS; to
communicate the ADRC’s progress and activities to our community; and to assure compliance with NIH
policies.